The Mechanistic Role of BRCA1-BARD1 DNA and RAD51 Binding in DNA Double-Strand Break Repair

ABSTRACT
Genomic instability is a hallmark of cancer, enabling the generation of mutations and gross chromosomal
rearrangements to drive neoplastic cell transformation and oncogenesis. A variety of conserved DNA repair
mechanisms eliminate DNA damage, and defects in these DNA repair pathways lead to genomic instability and
cancer. Homologous recombination (HR) is one such DNA repair pathway, which mediates the accurate repair
of highly toxic double-strand DNA breaks (DSBs) and damaged DNA replication forks. BRCA1 and its obligate
binding partner BARD1, both suppressors of breast, ovarian, and other cancers, fulfill multifaceted roles in HR.
Specifically, the BRCA1-BARD1 complex influences DSB repair pathway choice and enhances the efficiency of
several HR steps, including the nucleolytic processing of DNA lesions, the assembly of DSB repair nucleoprotein
complexes that harbor the recombinase RAD51, and DNA strand invasion. We posit that the DNA and RAD51
binding attributes of BRCA1-BARD1 are germane for the DSB repair and replication fork maintenance functions
of this tumor suppressor complex. To help fill major knowledge gaps, this fellowship proposal strives to delineate
RAD51 and DNA interaction interfaces in BRCA1-BARD1 and to elucidate the mechanistic roles of these
biochemical attributes in HR-mediated DNA repair and the protection of stressed and damaged DNA replication
forks. Our objectives will be accomplished through biochemical and cell-based studies under two specific aims.
The results of our endeavors will clarify the functional relevance of clinical mutations within BRCA1-BARD1
domains and create new avenues for the development of novel therapeutics to target tumors deficient in DNA
repair.

Public health relevance
PROJECT NARRATIVE The BRCA1-BARD1 protein complex acts to eliminate highly toxic DNA double-strand breaks, to ensure the faithful propagation of our genetic blueprint, and to suppress cancer development. However, there is little information regarding the intricate roles fulfilled by BRCA1-BARD1 in these processes, or how loss of specific BRCA1-BARD1 functions leads to tumorigenesis. Elucidating the DNA and RAD51 interaction interfaces of BRCA1-BARD1 and their function in DNA damage repair and DNA replication fork preservation will help illuminate the functional consequence of cancer mutations in BRCA1-BARD1 and lay the foundation for developing therapeutic strategies to target tumors deficient in DNA repair.